WARE-Care: a novel RF-based system to assess and prevent falling

Project Summary/Abstract
Many falls in nursing facilities are not reported during night when older adults are alone. It can lead to
reduced quality of life, increased fear of falling and restriction of activities, decreased ability to function, and
increased risk of injuries or death. We propose WARE-Care: mmWave based fall Assessment and
pRevEntion, as a non-intrusive system to work during the night to collect and assess older adults’ falling data.
WARE-Care will provide an accurate measurement of movement and be compact and easy to set up. The
system is safe, private, and user-friendly for nursing facility applications. The system is of strong interest to the
nursing centers, including the local Handmaker Jewish Services For Aging center.
The WARE-Care system is novel and unique and is based on the PI’s developments in mmWave radar
combined with advanced machine learning techniques. The new field of mmWave radar opens opportunities
for elders monitoring with significant advantages that complement existing visual and body-worn sensors.
mmWave radar operates in all lighting conditions and generates a point cloud that can be used to accurately
create a skeleton while respecting privacy, e.g. no detailed facial information will be collected. The non-touch,
non-obtrusive sensor can be preferred to battery limited and potentially irritating body worn sensors during
sleeping hours for elders. We will first build and verify the proposed system in different rooms including a
typical restroom and bedroom in the nursing home. We will then apply new neural-network based methods to
recover accurate skeleton movement and detect abnormal behavior of people regardless of age, sex, weight,
or height. We will first recruit a group of healthy adults (18 or older) for setting up and training the proposed
system. The system will further be validated on a targeted older group (65 and older), and be compared with
wearable motion sensors. An interdisciplinary team has been assembled to develop and perform initial clinical
validation of this novel system.

Public health relevance
Project Narrative A delayed/missed response to falling in nursing facilities can result in adverse consequences and even fatalities. WARE-Care: mmWave based fall Assessment and pRevEntion system, is proposed as a complementary tool to existed motion detection sensors (such as wearables and cameras) to capture the fall events and evaluate fall risks for elders living alone especially during night. The system will be non-contact and non-obtrusive, adhere to privacy protections, operate at safe electromagnetic radiation levels and is small, easy and practical to deploy.